Administrative Core

Abstract – Administrative Core
The CGR Administrative Core will be the central management arm of the Center and assist our early career
stage Research Project Leaders (RPLs), Pilot Project Investigators, mentors, and Core Directors to create a
state-of-the-art research center for the understanding of chromatin biology and epigenetic mechanisms of
genome regulation. Dr. Freeman along with Dr. Gorbsky and supported by administrative staff will ensure that
the scientific, fiscal, regulatory, and other management aspects of the CGR are efficiently completed. The
Administrative Core will: 1) Provide central management and logistical support for the COBRE, 2) Provide
mentoring for the Research Project Leaders and assist with their transition to scientific independence. 3)
Administer the Pilot Project program, 4) Promote multidisciplinary approaches to the research of and interactions
among the CGR investigators, 5) Coordinate the recruitment of new Research Project Leaders.